Characterize psychological and behavioral dimensions of cardiac arrest survivorship, and their association with 1-year mortality, cardiovascular disease risk, and health-related quality of life

Advances in healthcare, and effective public health campaigns to disseminate cardiopulmonary resuscitation
(CPR) and portable defibrillators, have doubled the survival rate for cardiac arrest (CA) in the last decade (from
16% to 33%). Patients whose hearts stop beating for many minutes are now resuscitated, kept in a medically
induced coma, and have their bodies cooled to 89°- 93°F (to reduce brain damage), resulting in many more CA
survivors returning to full lives. However, CA patients remain at markedly elevated risk for major adverse
cardiovascular events (MACE) and all-cause mortality (ACM), and many report poor health-related quality of
life (HRQoL) in the year after CA--despite returning to independence (and often to work) with cognition intact.
We propose that cardiac anxiety (i.e., cardiac specific-fear, avoidance behavior, and excessive cardiac symptom
monitoring) may partly explain MACE/ACM risk and poor HRQOL. It is highly prevalent in CA patients and
has been shown in non-CA cardiovascular disease (CVD) patients to be associated with higher rates of CVD-
related distress, avoidance of physical activity, patient-reported disability, and poor perceived health.
We will build a prospective cohort of CA survivors, comprehensively assess cardiac anxiety and other
psychological and behavioral consequences of CA in the first year of survivorship, and estimate the association
of cardiac anxiety, physical activity, and sleep with subsequent MACE/ACM and HRQoL. We will enroll a
cohort of 246 CA inpatients, assess psychological and HRQoL measures at enrollment, and by telephone at 1, 6,
and 12 months. We will assess physical activity and sleep by actigraphy for 2-weeks after discharge and again
for 2 weeks before a 6-month follow-up and follow participants for 12 months to MACE/ACM. This would be
the first major prospective cohort study of CA survivorship, and the first to objectively assess health behaviors.
For our Aim 1, we will estimate the prospective association of cardiac anxiety at CA discharge with subsequent
risk for CVD/mortality after adjusting for general psychological distress and other significant clinical covariates
and test its independent association with HRQoL. Our second aim is to test whether cardiac anxiety after CA is
associated with low physical activity and/or short sleep shortly after discharge. Physical activity (PA) and sleep
are implicated in CVD risk and chronic disease progression, but no study has assessed PA or sleep in CA
survivors. Our pilot data suggest that survivors of other acute cardiac events report avoiding physical activity
because it causes threatening physiological signals (i.e., increased heart rate, shortness of breath), and poor
sleep due to cardiac anxiety. Lastly, our third aim is to quantify the extent to which low PA and/or short sleep
after CA predict MACE/ACM, and mediate the association between cardiac anxiety and 12-month MACE/ACM
post-discharge for CA. By identifying malleable intervention targets for improving both CVD/mortality risk and
post-CA quality of life, this study could ignite the development of the first generation of CA survivorship
interventions.

Public health relevance
PROJECT NARRATIVE Many cardiac arrest (CA) patients now survive neurologically intact, but evidence from the new field of CA survivorship research suggests that cardiac anxiety, physical inactivity, and poor sleep are common—and may increase survivors' high cardiovascular and mortality risk. This will be the first cohort study of CA survivors to comprehensively assess psychological distress, objectively monitor physical activity and sleep, and rigorously adjudicate cardiovascular events and mortality at 12 months after hospital discharge. In a diverse group of CA survivors, we will estimate the prospective association of cardiac anxiety and behavioral factors with CVD event-free survival and quality of life, to provide the most rigorous data to date on psycho-behavioral contributors to secondary risk in CA patients.